DNA damage tolerance pathway choice in Drosophila

DNA damage tolerance pathway choice in Drosophila
Project Summary
When replication forks encounter DNA lesions, they must bypass these roadblocks through
DNA damage tolerance mechanisms or DNA synthesis will stop, leading to gaps in the genome,
genomic instability, and eventual cell death. Strategies that cells use for bypass include the
recruitment of error-prone translesion synthesis polymerases, template switching at the
replication fork, and repriming downstream of the lesion followed by gap filling. The choice of
damage tolerance mechanism is important, as some pathways are more mutagenic than others.
However, the control of lesion bypass pathway choice in metazoans is not well understood,
particularly in the context of different tissues. Such knowledge is critical in order to understand
how both normal and cancerous cells deal with replication-blocking lesions that result from
treatment with chemotherapeutic agents.
We have recently discovered that the REV1 protein is a key mediator of DNA damage tolerance
in Drosophila. REV1 promotes the recruitment of translesion polymerases to bypass damaged
bases, which we have shown is the preferred tolerance mechanism in rapidly dividing tissues in
the developing fly. In addition, REV1 appears to mediate template switching through an
unknown mechanism. In the experiments described here, we will use domain-specific mutants,
genetic analysis, and cellular assays in larval imaginal discs to characterize how REV1
coordinates various damage tolerance pathways to promote continuance of DNA replication. In
addition, we will use both genetic and biochemical methods to identify new proteins involved in
damage tolerance. Our investigations will be aided by novel techniques that we have developed
to assess DNA repair and mutagenesis in both cells and tissues and by a rich collection of DNA
repair and replication mutants. The use of whole Drosophila in our experimental design provides
us with an opportunity to study damage tolerance in the context of tissue specificity and
development. Together, our proposed studies will advance our long-term goal to understand
why different DNA damage tolerance mechanisms are preferentially used in different contexts
and how this choice of bypass strategy impacts cellular survival and genome stability.

Public health relevance
PROJECT NARRATIVE DNA damage created by treatment with chemotherapeutic agents can prevent cells from copying their DNA and cause genome instability and cell death. To bypass DNA damage, cells employ many damage tolerance strategies, some of which result in DNA mutations. The goal of this proposal is to elucidate how cells choose between various options for damage bypass and how these choices affect the long-term stability of the genome.